Advancing a Platform Technology for C. difficile Infection Treatment: the Promise of Antisense Oligonucleotides

ABSTRACT
Clostridioides difficile infection (CDI) is a debilitating diarrheal disease that is precipitated upon antibiotic-induced
gastrointestinal tract dysbiosis. Currently, there is no vaccine to prevent CDI, and the primary FDA-approved
treatment relies on substantial antibiotic use. In the hospital as well as community, the elderly and immune-
compromised are at most risk; therefore, CDI is a significant problem worldwide. The causative agent, C. difficile,
is an anaerobic, spore-forming bacterium designated as an “Urgent Threat” to US healthcare.
To date, there is a paucity of organism-specific (precision) antibacterials. Therefore, we developed a novel,
water-soluble, cationic bolaamphiphile (CAB) platform nanocarrier, and complexed it with an antisense
oligonucleotide (ASO) targeting the essential C. difficile dnaE gene. In preliminary studies, this dnaE*964
nanocomplex was bactericidal, with a C. difficile Minimum Inhibitory Concentration (MIC) comparable to a
standard-of-care CDI antibiotic, vancomycin. Crucially, dnaE*964 was inactive against a panel of human
intestinal commensal organisms. Pharmacokinetic (PK) assessments in mice and Golden Syrian hamsters
revealed that the CAB nanocarrier was safely tolerated, and that it preferentially accumulated in the rodent GI
tract; thus, a dosing regimen was defined. In pilot efficacy studies, dnaE*964 ablated CDI pathology, cleared C.
difficile from the rodent cecum and stool, and maintained microbiota restitution. dnaE*964 clinical development
is therefore in progress.
To expand the utility of our CAB platform and also address the inevitable clinical concern of single-target
resistance development, we will now evaluate 3 additional ASO leads targeting C. difficile genes encoding
cytoplasmic as well as cell wall-associated proteins; all are essential. Preliminary studies reveal that
phosphorothioated ASOs customized for each gene completely ablate expression and also inhibit C. difficile
growth in a dose-dependent manner. We thus hypothesize that ASO*CAB nanoparticles targeting essential
genes (1) will specifically kill C. difficile in vitro and in vivo, and (2) can functionally synergize with each other
and with standard-of-care antibiotics without significantly engendering resistance emergence. In vitro (Aim 1;
MIC, resistance) and in vivo (Aim 2; efficacy, microbiota sparing) studies will test these hypotheses.
Taken together, we thus prioritize key pre-clinical assessments of CAB-based bacterial anti-infectives. Studies
in both Aims will be underpinned by quantitative milestones that will inform the translational pathway via a clear
framework for go/no-go decisions.

Public health relevance
NARRATIVE The diarrhea-causing organism Clostridioides difficile is responsible for high levels of illness and death. There are currently no options for preventing C. difficile infections, and very few therapeutic choices for treating the disease. In this application, we propose to test the potential of a new and versatile nanovesicle-based therapeutic, including in combination with currently-used antibiotics, to effectively treat C. difficile infections and constrain the bacteria’s ability to become resistant to treatment.